Emerging Infectious Diseases Research Center - East and Central Africa

PROJECT SUMMARY
Since 2012 when the first human case of Middle East respiratory syndrome coronavirus (MERS-CoV) was
confirmed, the World Health Organization has reported >2220 human infections and almost 800 deaths spread
across 27 countries located in the Middle East, Europe, Asia, and the United States. Although dromedary camels
are the known reservoir of the virus, there is limited knowledge on the mechanisms and factors associated with
camel-to-human transmission, which remains the primary mechanism of human infections. Human outbreaks
and the number of documented cases of MERS-CoV continue to grow in the Middle East and Asia; however
there have, to date, been no documented cases of human disease in the eastern Africa countries where >65%
of the world’s dromedary camels are found. This is despite evidence of prevalent MERS-CoV infection of camels
in the region. The absence of human disease in East Africa may be explained by viral plasticity resulting in
inefficient transmission and/or weakened virulence, or poor disease surveillance and reporting among the
marginalized camel-owning nomadic pastoralist populations that inhabit remote arid lands of the regions. We will
test these hypotheses by conducting integrated longitudinal cohort studies within a closed community of naïve
pastoralists and their camel population that is known to sustain MERS-CoV circulation in Marsabit County,
Kenya, in order to determine the maintenance and transmission of the virus among camels, zoonotic
transmission to humans, and severity of human infections. To determine if the circulating MERS-CoV is
genetically and phenotypically distinct from known virus clades in the Middle East and Asia, we will isolate the
East African virus by collecting samples biweekly from an infant cohort (birth -1 year) of 211 camels, followed by
culture and isolation of the virus to performed genotypic and phenotypic comparison with the known clade viruses
To investigate whether a combination of weak surveillance and poor access to health care are responsible for
absence of disease, we will follow-up for a year, a cohort of 573 camel handlers through biweekly visits, weekly
telephone calls, and access to a toll-free number in order to intensively examine and test them for MERS-CoV
disease. In addition, we will identify, test, and follow-up >4500 in- and out-patients with respiratory illness at
Marsabit County Referral Hospital for 3 years. To assess the risk the virus poses to humans, we will determine
the level of viral shedding in camels, and relate this to the incidence of zoonotic transmission, and types of camel
contact that increase transmission risk. These studies will identify the type of virus circulating in East Africa,
increasing knowledge about plasticity of MERS-CoV and its impact on zoonotic transmission and disease. By
elucidating the frequency and mechanisms of zoonotic transmission, and progression to clinical human disease,
we will define the risk the virus poses to this community at the frontline of a newly emergent virulent virus by
virtue of their occupation and lifestyle, paving the way for development of improved surveillance and appropriate
prevention and control strategies.

Public health relevance
PEROJECT NARRATIVE The east and central Africa (ECA) region is a global hotspot for emerging infectious diseases (EID), associated with recurrent outbreaks of viral hemorrhagic fevers and detection of viruses emerging elsewhere that are capable of causing high morbidities and mortalities such as highly pathogenic influenza, Zika, and Middle East respiratory syndrome coronavirus (MERS-COV). We propose to establish an Emerging Infectious Disease Research Center (EIDRC), headquartered in Nairobi but with surveillance distributed throughout the region. The Center will conduct pilot research on maintenance and transmission of RVF virus and MERS-CoV; conduct systematic pathogen discovery and development of diagnostics and research reagents; and support response to outbreaks of suspected EID the region by conducting timely clinical and socio-cultural outbreak research that enhances characterization of outbreaks, leading to implementation of prevention and control measures.